Discovery and optimization of ApoE4 correctors for the treatment of Alzheimer's Disease

PROJECT SUMMARY
Alzheimer's disease (AD) is a major public health crisis with no effective treatments. Apolipoprotein E (ApoE)
has three major polymorphic alleles, denoted ApoE2, ApoE3, and ApoE4. Homozygosity for ApoE4 is the
strongest genetic risk factor for AD with an astonishing 12-fold increased risk of developing AD compared
with individuals who inherit ApoE3.1,2 ApoE4 differs from ApoE3 by a single amino acid, an arginine instead of
cysteine at position 112. This small change presumably alters the conformation of the protein, altering its
activity in many biological pathways resulting in both gain and loss of function.1,3 Given the dramatic impact of
ApoE4 on AD biology (including increased amyloid deposition, faster rate of progression, decreased synaptic
content), there have been attempts to identify a small molecule that binds to ApoE4 and makes it functionally
similar to ApoE3, a so called “corrector”. Yet this has been challenging: Generating purified ApoE4 protein has
proven to be difficult, as the protein is notoriously sticky and readily aggregates. Multiple mutations in the C-
terminal region are required to enable ApoE purification and structural determination.4 We and others have
shown that analysis of such purified protein in a Protein Thermal Shift assay (PTS) shows that ApoE4 is >4oC
less thermally stable than ApoE3.5 We have extended this finding by now demonstrating that lysates from the
brains of humans or humanized ApoE transgenic animals when analyzed by an analogous technique, a
CEllular Thermal Shift Assay (CETSA)6 also show that brain ApoE4 is less thermally stable compared to
ApoE3. As CETSA is a low throughput assay, we engineered a HiBiT tag on to the N-terminus of ApoE to
derive a split Nano-luciferase HiBiT cellular thermal Shift Assay (BiTSA)7,8 in HEK 293 cells, and miniaturized
this assay to a 384 well format. Excitingly, we show that the thermal stability of ApoE4 measured by BiTSA can
be “corrected” to that of ApoE3 by a recently published ApoE4 corrector (compound 8, EC50 <3uM) 9),
discovered by scientists at AbbVie and a previously published genetic “corrector” – the Arg61T mutation. We
have synthesized 30 analogs of compound 8 in a Hit to Lead effort and demonstrate nascent SAR and
potential paths forward to optimize this series for in vivo use. Our research plan has three aims: 1) identify
new ApoE4 corrector by screening 250,000 compounds deploying the ApoE4 PTS assay as a primary
assay and the ApoE4 BiTSA as a secondary assay 2) drive medicinal chemistry optimization of
compound 8 and hits identified in the HTP screen and 3) test the hypothesis that these correctors can
ameliorate ApoE4 related Alzheimer phenotypes both in vitro and in vivo using cell and murine models
that we and others have developed. These efforts represent initial steps towards our overall long-term
objective, discovering first in class ApoE4 correctors as therapeutics for AD.

Public health relevance
PROJECT NARRATIVE APOE4 is the greatest known genetic risk factor for sporadic Alzheimer's and there exists a high unmet medical need for therapeutics that could prevent disease associated with this variant. We have developed an innovative split luciferase assay that can detect the binding of compounds to ApoE4 in cells. We propose to leverage this breakthrough to both discover new and optimize known ApoE4 correctors into drugs that can generate in vivo proof of concept that they can functionally correct ApoE4 pathobiology in murine models and ultimately be developed into a therapeutic for AD.